Genetics of Osteoarthritis and Joint Replacement Recovery: Key to Precision Rehabilitation

The societal and patient-centered impacts of end-stage osteoarthritis (OA) among United States
Veterans are profound. More than 30% of Veterans in the VA healthcare system have OA which is significantly
higher than in the general population. VA treatment costs for OA are high, exceeding $880 million annually. Still,
apart from pain and symptom management and end stage surgical intervention, there are no effective therapeutic
treatments for OA. Despite prescribed rehabilitation post-surgery, Veterans who undergo total hip arthroplasty
(THA) or total knee arthroplasty (TKA) experience profound deficits in health-related quality of life (HRQL),
severe limitations in activities of daily living, increased healthcare utilization, and higher incidence of
comorbidities. OA has a strong genetic component with heritability estimates >30%. Our research in the Million
Veteran Program (MVP) cohort led to discoveries in key areas. First, our ancestry specific and multi-ancestry
analyses in over 477,000 MVP and the UK Biobank (UKB) participants identified of novel genetic regions
associated with OA. Second, OA frequency was higher in the MVP than in our replication cohort (UKB) despite
using identical electronic health record diagnosis codes which may have hampered replication efforts. Third,
our research in the MVP cohort demonstrated a higher OA heritability in African American and Hispanic Veterans
than those of European White descent. Our overall goal is to identify pre- and post-rehabilitative biomarkers
to enhance physicians’ intuition for predicting patient prognosis for Veterans with OA and/or PTOA.
Toward this goal and to fill important knowledge gaps regarding the association of genetic factors with OA and
outcomes, in Aim 1, a) we will confirm genetic variants associated with OA prevalence and progression to end-
stage OA as well as b) develop and evaluate the performance of a polygenic risk score (PRS) to identify Veterans
at risk of progression to total hip/knee joint arthroplasty; in Aim 2, we will identify genetic variants prognostic of
THA/TKA recovery; and in Aim 3, we will determine whether genetic variants associated with the development
of post-traumatic OA (PTOA) are distinct from known genetic determinants of idiopathic OA. We will identify
biomarkers to enable targeted, precision pre-habilitation and post-surgical rehabilitation strategies improving
mobility function, HRQL, and healthcare utilization among Veterans with OA.

Public health relevance
Osteoarthritis (OA) is a common medical problem for US Veterans. More than 30% of Veterans in the VA healthcare system have OA, higher than in the general population in the US. OA is often painful, and leads to poor quality of life, making it hard to lead a fully functional life, and when it progresses, can be debilitating. Drugs prescribed to alleviate joint pain and joint replacement are the only effective treatments. However, joint replacement surgeries are expensive and even after surgery and rehabilitation, many Veterans still do not regain significant improvements in quality of life, have difficulties performing regular daily activities, need additional care and are more likely to be hospitalized. OA has a genetic component. Therefore, there is a potential to provide insight to why some Veterans develop OA and why some progress to end-stage disease with limited recovery to joint replacement surgery. We propose to follow-up our previous work where genetic analyses led to discoveries with striking potential for translation to clinical care, i.e. findings that will be meaningful to Veterans with OA.